The Role of Adaptation and Resilience in a Changing Climate: Cardiovascular Risk and Allostatic Load Among Youth

PROJECT SUMMARY (RESEARC PROJECT 2: The Role of Adaptation and Resilience in a Changing
Climate: Cardiovascular Risk and Allostatic Load Among Youth)
Climate change (CC) is rapidly intensifying, and while mitigating CC is a critical goal, there is an urgent need to
reduce vulnerability to its cardiovascular health (CVH) impacts. Of the rapidly emerging CC threats, heat stress
and wildfire (WF) smoke are strongly linked to adverse CVH outcomes, yet little is known about how CC may
influence CVH profiles across the age spectrum, particularly in youth when adaptation strategies to increase
resilience may be most impactful on long term health. Growing evidence indicates measures of CVH in youth
are associated with cardiovascular endpoints and events in adulthood. While studies have linked air pollution
exposures with early cardiovascular changes in youth, less is known about WF smoke, heat stress, and how co-
exposure may influence these relationships. This question is critical for individuals and communities with lower
CC adaptive capacity and resilience which helps withstand and quickly recover from CC-related hazards.
Allostatic load (AL) correlates with reduced biological resilience to the effects of environmental exposures and
stressors. The AL model posits repeated chronic exposure to (or anticipation of) hazards and stressors – similar
to those experienced with CC - can dysregulate the body's adaptive systems leading to “wear and tear” on organ
systems and greater risk of adverse outcomes over the life course, including CVH. Recent evidence has linked
CC with stress, anxiety, and mental health impacts due to experiencing or anticipating CC hazards; however,
few studies have begun to conceptualize AL's role in CC adaptation and resilience. We hypothesize AL may
serve as a sensitive early indicator of individual, biological resilience to CC-related heat stress and WF smoke
exposures and risk of adverse CVH across the life course. We will investigate these questions in the MetaAir2
cohort, a subset of the Southern California Children's Health Study with 20+ years of active follow-up and
comprehensive CVH assessment of young adults starting in childhood. We aim to understand how lifetime heat
stress and WF smoke exposure independently and jointly impacts blood pressure and pulse rate over time (Aim
1), and AL (Aim 2) in adulthood. We will assess whether neighborhood climate adaptation vulnerabilities (e.g.,
urban heat islands, tree canopies, climate and social vulnerability indices) could modify risk (Aim 3). We will
investigate the association between AL and carotid ultrasound measures of vascular injury in adulthood to inform
AL's utility as an early marker of adverse CVH outcomes and a precision screening measure of individual
biological resilience to CC (Sub-Aim). Developing a greater understanding of CVH impacts of lifetime heat stress
and WF smoke and AL's utility as a personalized measure of biological resilience to CC can inform targeted and
scalable risk screenings. Evaluating the role of neighborhood adaptation vulnerabilities in this context is critical
to designing interventions and action plans that increase climate resilience and mitigate long term CVH impacts.